Molecular Biology Core

PROJECT SUMMARY
All the Phase II CoBRE projects utilize molecular biology approaches to understand the molecular
mechanisms of respiratory diseases caused by respiratory pathogens, including influenza virus (Project 1 and
Project 2), Streptococcus pneumoniae (Project 3) and Pseudomonas aeruginosa (Project 4). The overall
objective of the Molecular Biology Core (MBC) is to provide centralized services and technical expertise in
molecular biology for Phase II CoBRE project investigators, pilot project investigators, and other investigators.
The specific aims of the MBC are to provide services and support for 1) functional studies using RNAi and
CRISPR/Cas9, transgene overexpression, and mutagenesis/deletion, 2) genome-wide gene profiling using
RNA sequencing, 3) molecular assays including reporter assays and real-time quantitative PCR, 4) reagents
for respiratory and infectious disease research including primary lung cells, respiratory viruses and bacteria,
and 5) advice, consultation and training on various aspects of molecular biology and developing or adopting
new methods as needed.